Research Training in Otolaryngology

Project Summary
The purpose of the proposed resubmission for “Research Training in Otolaryngology” is to provide a two-year
period of uninterrupted research training for one individual per year during the course of clinical residency
training in otolaryngology-head and neck surgery. As in the past, the clinical training program at
Harvard/Massachusetts Eye and Ear has two separate tracks, a clinical track and a research track, and
it is in this latter research track that training will be supported. The educational objective of the training program
is to prepare the selected trainees for an academic career in otolaryngology-head and neck surgery and to
place them soundly on a trajectory toward successfully competing for peer-reviewed research funding.
The program provides opportunity for research training in established laboratories under the mentorship of
individuals with a track record of peer-reviewed research support in a wide variety of research environments in
the Department of Otolaryngology – Head and Neck surgery at the Massachusetts Eye and Ear, its affiliated
hospitals, including Children’s Hospital of Boston, Massachusetts General Hospital, Brigham and Women’s
Hospital, Harvard Medical School, and the Massachusetts Institute of Technology. The research opportunities
include a wide variety of basic, clinical, and translational research in hearing, balance, laryngology, and voice,
molecular biology and genetics, head and neck neoplasia, rhinologic disease, neurobiology of head and neck
pathologies, and neuroprostheses.
The applicants will be drawn on a yearly basis from a pool of nearly 400 applicants for residency training in
otolaryngology, which includes specific recruitment of individuals from underrepresented racial/ethnic groups.
The educational program includes training in responsible conduct of research, research methodology to
enhance reproducibility, and specific mentorship in the application process for peer-reviewed funding. The
applicant pool will be interviewed by a residency selection committee which includes representation from
members of the research community.

Public health relevance
Project Narrative The true benefit of biomedical research to public health depends upon swift and efficient translation of scientific discoveries into the healthcare domain. This translation is accomplished first and foremost by the cadre of “bilingual” clinician-scientists who are at home in both the world of science and the world of clinical medicine. Our program aims precisely to nurture the development of such clinician-scientists in the field of otolaryngology – head and neck surgery.